HiDef B8: Commercialization and scaled production of defined, robust, and cost-effective media for iPSCs

RESEARCH & RELATED Other Project Information
Defined Bioscience, Inc.
7. PROJECT SUMMARY
Inconsistency of growth media for cell culture is a significant problem in both industry and academia that has
plagued laboratories for decades. In biopharma, cell-based and cell-derived therapies are growing at a
tremendous rate and require well-defined, animal-free components to meet FDA and cGMP regulations. It is
therefore not surprising that there is an increased need for and adoption of serum-free media for cell culture
growth that is attributed to its superior batch-to-batch consistency and reduced risk of unwanted
animal/xenobiotic contaminants. This is particularly critical to human induced pluripotent stem cells (hiPSCs), a
rapidly evolving technology with wide research and clinical application. These cells present numerous
advantages compared to previous technologies, including human origin, the ability to form multi-class cell
systems and tissues, relative ease of production and modification, and functional relevance. Robust and well-
characterized protocols are of utmost importance when culturing hiPSCs for downstream applications. High
pluripotency, genetic stability, large-scale production and maintained function all must be kept in mind for
hiPSCs. Yet despite the array of defined media now available for iPSCs, many of these media fail to satisfy the
full needs of hiPSC research, including robustness over multiple passages and experimental needs, low cost,
ease of production, weekend-free media changes and fully defined components. Such traits are critical for robust,
consistent and affordable research in the hiPSC space.
Just this year, our Defined Bioscience team empirically tested common defined media components over a large
array of concentrations and combinations, isolating a well-defined recipe with high robustness, efficacy over
>100 cell passages, and maintained success in a weekend-free passaging schedule. This media, termed B8 by
the lab of scientific advisory board member Paul Burridge, met or exceeded the expectations for a Phase I SBIR
development proposal. Here we will extend this work to prepare HiDef B8, a formulation of B8 finalized to optimal
component concentrations and reduced cost. This optimized formulation will be tested across academic and
industrial labs in the United States to confirm robustness and efficacy in streamlined and applied hiPSC culture
and methodologies. We intend to make HiDef B8 an affordable, defined media for robust hiPSC culture across
high passage numbers and in a weekend-free context, significantly reducing the cost and complexity of hiPSC
technologies across the field. This will enable stable cell culture and a well-characterized starting point for
subsequent differentiation and applied hiPSC technology efforts, while simultaneously lowering the barrier of
entry for hiPSC development in the field.

Public health relevance
8. PROJECT NARRATIVE Human induced pluripotent stem cell (hiPSC) culture is plagued by poorly defined, inconsistent, and costly media recipes for maintained pluripotency. Our team has developed a formulation, termed B8, that is low-cost, robust, effective at high-passage counts, and is fully defined. This project aims to finalize the B8 formulation to HiDef B8, with increased characterization, low commercialization cost, and a more robust weekend-free usage protocol, for application in hiPSC cell maintenance and differentiation studies.